Gut Bacteriophage Correspondence with Inflammation and Clinical Dietary Interventions

Project Summary – NIH F32 Fellowship – Andrew Brooks – P.I. Mike Snyder
Application Title: Gut Bacteriophage Correspondence with Inflammation and Clinical Dietary Interventions
Recurring gastrointestinal inflammation contributes to chronic non-transmissible diseases like diabetes,
inflammatory bowel disease, and colorectal cancer that afflict millions of Americans. A primary culprit is the gut
microbiome, which is filled with trillions of bacteria and roughly as many predatory bacteriophages. Many gut
phages are temperate, meaning they can cycle between dormant lysogenic prophages and active lytic phage
particles that attack bacterial hosts. There are many direct and indirect mechanisms through which lytic phages
trigger human immunity, yet whether those result in significant inflammatory responses is unknown. Therefore,
it is critical to investigate the hypothesis that phages periodically contribute to gut inflammation during
peaks in active lytic growth. Knowing whether phages significantly impact gut inflammation will be important
as new evidence suggests phages are transmitted from mother to child, passed through fecal microbiome
transplants, and persist within individuals for long periods. Phage persistence and growth are closely tied to
availability of nutrients and bacterial hosts, and human diet shapes gut metabolites which in-turn affect bacteria
in the microbiome. This suggests the second hypothesis, that dietary metabolites and their effects on gut
bacteria can predict and shape phage activity.
This project is well positioned to comprehensively address both aims by leveraging three temporal human
studies within the Snyder lab and Stanford University which have proven research records instilling the
foundations for productive academic careers. Participant samples are undergoing extensive multi’omic profiling
(immunity, metabolism, genomics…), which will be related to gut phage and microbiome profiles generated using
high throughput metagenomic sequencing. Immune profiles from blood and stool will quantify gut inflammation
alongside metagenomic measures of gut phage activity. The expectation of the first hypothesis is that peaks in
phage lytic activity will associate with increased inflammatory biomarkers. Two of the studies also involve clinical
dietary interventions, providing controlled perturbation to address the second hypothesis that diet predicts and
shapes phage activity. The expectation is that profiles of gut metabolites and bacteria are predictive of phage
activity, and therefore clinical dietary effects on gut metabolites and microbiomes can shape phage growth. Aims
will be addressed in three multi’omic studies examining diverse aspects of human health. This facilitates
comprehensive scientific validation in an expert collaborative environment supported by a robust mentorship
team. Pursuit will provide a population scale examination of human gut phages in an unprecedented multi’omic
context, while the first aim examines phage activity as a factor in America’s most burdensome gastrointestinal
diseases, and the second examines diet as a means to predict and shape that gut phage activity.

Public health relevance
Project Narrative – NIH F32 Fellowship – Andrew Brooks – P.I. Mike Snyder Application Title: Gut Bacteriophage Correspondence with Inflammation and Clinical Dietary Interventions Trillions of diverse bacteriophages in the human gut alternate between dormancy and actively preying on bacterial hosts, but it is unknown if phage activity is predictable, shaped by diet, or corresponds with gut inflammation. Profiles of gut phages, metabolites, immune markers, and other microbes will be compared across three temporal human studies to investigate: dynamics of phage activity, phage responses to clinic dietary interventions, and phage roles in triggering immune responses. As phage therapies and roles shaping the microbiome gain new recognition, it will be a great benefit to comprehensively examine the dynamics and human health effects of natural gut phages across human populations with varying temporal scales and clinical interventions.